Adoptive T cell Therapy of Melanoma Targeting NY-ESO-1

DESCRIPTION (provided by applicant): The successful application of adoptive cellular therapy for the treatment of patients with cancer involves a constructive interplay of intrinsic and extrinsic factors. Initial studies performed by our group and others initially focused on the use of antigen-specific CD8+ T cells alone or in combination with an extrinsic growth factor, IL-2. On its own, this strategy brought limited responses, and efficacy was dependent on another extrinsic factor, pre-infusion conditioning. However, the intrinsic capacity to persist in vivo rests primarily with CD4 T cells and we sought in our original application to evaluate the safety and duration of in vivo persistence of adoptively transferred CD4 T cell clones in a dose escalation study. This study yielded a durable clinical response and small number of partial or minor responses in patients receiving CD4 T cells alone. To enhance efficacy, we now propose a Phase I/II clinical trial to evaluate the contribution of an extrinsic component, pre-infusion conditioning, to the in vivo persistence of adoptively transferred antigen-specific CD4 T cell clones, to eliminate regulatory components and together, broaden the antigen-specific immune response as a means of preventing the outgrowth of antigen-loss variants. In addition, preclinical studies will be performed to develop strategies that modulate intrinsic properties of antigen-specific CD4 T cells and are designed to expedite the generation of antigen-specific CD4 T cells and enrich for a population with a desirable central memory and pro-inflammatory (Th17) phenotype PUBLIC HEALTH RELEVANCE: Cancers that are resistant to standard chemotherapy and radiation may be treatable using components of the immune system. We propose to use specialized long-lived immune cells, CD4 T cells, that recognize targets on tumor cells as a means of treating patients with advanced (metastatic) melanoma. By isolating and expanding such T cells and infusing them into patients, together with a treatment that increases T cell survival and killing ability, we hope to identify a therapy that will be safe and will improve the effectiveness of melanoma-specific T cells.

Public health relevance
Project Narrative Cancers that are resistant to standard chemotherapy and radiation may be treatable using components of the immune system. We propose to use specialized long-lived immune cells, CD4 T cells, that recognize targets on tumor cells as a means of treating patients with advanced (metastatic) melanoma. By isolating and expanding such T cells and infusing them into patients, together with a treatment that increases T cell survival and killing ability, we hope to identify a therapy that will be safe and will improve the effectiveness of melanoma-specific T cells.